Discovering targeted modulator of microglial activity as a candidate treatment for FTD and related dementias.

PROJECT SUMMARY/ABSTRACT
Frontotemporal dementia, often classified as Alzheimer’s disease related dementia, is a devastating disease
with a common onset between the ages of 40 to 65 that affects estimated >50,000 people just in the US. The
disease is a result of progressive degeneration of frontal and temporal lobes of the brain that can result in wide
variety of devastating symptoms including severe behavioral changes, speech and language problems, motor
disorders, and survival of 3-12 years, but no therapies slowing the progression of this age-related
neurodegenerative disease are available.
We propose undertaking a project to rapidly discover a novel oligonucleotide therapeutic for direct modulation
of a genetically validated target involved in pathologic neuroinflammation. Microglia-driven neuroinflammation
has emerged as a critical pathologic mechanism in FTD and other age-related neurodegenerative diseases. We
found that our target expression level is significantly increased in FTD-ALS, which is the most severe version of
FTD. Consistently with published literature from other neurodegenerative diseases, we find that the lower
expression of the genetic target is correlated with longer patient survival, and its hypomorphic gene variant is
associated with late disease onset. This project leverages our high-throughput iPSC platform with diverse genetic
models of FTD to provide robust functional evidence for further development of the candidate drug.
Successful completion of the proposed drug discovery project will deliver a candidate therapeutic for FTD
that will be ready for in vivo studies. The mission of our company is to efficiently deliver novel therapeutics to
patients with devastating age-related diseases using our lean company model and high-throughput, automated
drug discovery platform anchored in human genomic data paired with clinical measurements.

Public health relevance
PROJECT NARRATIVE Neuroinflammation is a common pathologic mechanism in neurodegenerative diseases for which there are currently no effective cures, but a large number of single-nucleotide polymorphisms that are predicted to alter RNA expression and splicing in microglia, the CNS resident cells driving neuroinflammation, were found to be strongly associated with the risk of age-dependent neurodegeneration. The risk, onset, and progression of disease is often affected by the context of specific disease mutations and patient genetic background, but limited efforts were made to directly modulate function of the disease modifying genes in glia. Aperture Therapeutics, Inc. is developing a high-throughput target validation and drug discovery platform that embraces the genetic diversity to develop novel therapeutics for FTD and other neurodegenerative diseases with pathologic neuroinflammation.